Impact of Adaptive Immune System on Cardiac Electrophysiology

Project Summary
Heart diseases, including myocardial infarction (MI), heart failure (HF) and cardiac arrhythmias are the leading
causes of morbidity and mortality within developed nations. However, our limited understanding of the
mechanisms leading to cardiac dysfunction in HF has hampered the development of effective treatment
strategies for these patients. Activation of CD4+ T-cells post-MI promote wound-healing and scar formation.
However, we have shown that by 8 weeks post-MI, CD4+ T-cells undergo a temporal phenotypic switch that
promotes pathological left-ventricular (LV) remodeling and the development of ischemic HF. Importantly, we
have shown that during HF, splenic CD4+ T-cells are enriched with antigen-experienced and central memory T-
cells, and their adoptive transfer (AT) to naïve mice induce cardiac dysfunction and LV-remodeling, suggesting
that CD4+ T-cells contribute to cardiac dysfunction in HF. However, the mechanisms by which HF-activated CD4+
T-cells induce cardiomyocyte (and cardiac) dysfunction are unknown. Our preliminary data show that upon AT,
significantly higher numbers of HF-activated CD4+ T-cells (compared to sham T-cells) infiltrate the myocardium
of naïve mice (almost 80-85% of all CD4+ T-cells), and induce significant cardiac dysfunction, arrhythmic events,
myocyte hypertrophy and LV remodeling in naïve mice. Importantly, co-culture of adult mouse cardiomyocytes
with HF-activated T-cells alter electrophysiological function of cardiac myocytes through pro-arrhythmic changes
in cardiac currents. Notably, HF-activated T-cells form functional connexin43 gap junctions (Cx43 GJs) with
cardiomyocytes and, we demonstrated that changes in currents induced by HF-activated T-cells are contact-
dependent. This, contact-dependent alteration of cellular electrophysiology and overall cardiac
dysfunction induced by pathological CD4+ T-cells represent a heretofore-unappreciated mechanism
contributing to HF and arrhythmias . Thus, we will test the overall hypothesis that HF-activated T-cells
promote LV remodeling, cardiac dysfunction and arrhythmias during chronic HF through Cx43 mediated contact
with cardiomyocytes. We will test this hypothesis using the following aims: 1. To delineate the pathophysiological
role of ischemic HF (IHF) activated CD4+ T-cells on cardiac dysfunction. 2. To determine electrophysiological
changes in cardiomyocytes resulting from HF T-cells. 3. To delineate the role of gap junctions in mediating
pathological effects of T-cells on cardiomyocyte/cardiac function. These studies will identify mechanisms that
mediate contact-dependent pathological effects of HF-activated T-cells on cardiomyocyte electrophysiology and
overall cardiac dysfunction, thereby furthering our understanding of the cellular basis for inflammation in this
disease. PIs are trained scientists in cardiomyocyte electrophysiology and cardiovascular T-cell biology, and we
are collaborating with experts in gap junctions, computational modeling and arrhythmia mechanisms, making us
an exceptional team to conduct these studies.

Public health relevance
Project Narrative Despite the knowledge that CD4+ T-cell activation is required for wound healing during myocardial infarction (MI) but exacerbates left-ventricular remodeling and cardiac dysfunction during heart failure (HF), the specific mechanisms that mediate pathological effect of T-cells on cardiac function are not known. Our preliminary results suggest that adoptively transferred HF-activated CD4+ T-cells, in contrast to sham T-cells, infiltrate into the hearts of naïve mice, induce cardiac dysfunction, augment the risks for arrhythmias and alter cardiac cellular electrophysiology in a contact-dependent manner with the cardiomyocytes. In the proposed study, PIs intends to study the role of gap junctions formed between HF-activated CD4+ T-cells and cardiomyocytes in mediating pathological effects of T-cells during HF.